Comprehensive Health Informatics Engagement Framework for Pulmonary Rehab

Previous studies clearly established clinical benefits of pulmonary rehabilitation in patients with chronic
obstructive pulmonary disease (COPD) however uptake and completion rate of pulmonary rehabilitation (PR)
programs by these patients is limited by multiple barriers. We developed a t Comprehensive Health Informatics
Engagement Framework for Pulmonary Rehabilitation (CHIEF-PR) which facilities patient referral and
promoted adherence with pulmonary rehabilitation program using innovative multi-pronged approach. It
includes computer-mediated patient counseling to increase patient motivation in joining PR program followed
by ongoing home-based support of PR by a telerehabilitation system that monitors patients' progress and allows
remote oversight by clinical PR team. The goal of this project to systematically evaluate impact of
Comprehensive Health Informatics Engagement Framework for Pulmonary Rehabilitation (CHIEF-PR) in a
randomized controlled trial. Our main hypothesis is that CHIEF-PR will result in significantly higher rates of
completion of a comprehensive pulmonary rehabilitation program. We will enroll 120 COPD patients within 4
weeks of acute exacerbation of COPD into randomized controlled trial and follow them for 12 months. Patients
will be randomly assigned to intervention (CHIEF-PR) and control (best available standard of care) groups.
Primary outcome will be completion rate of comprehensive 3-month PR program. Secondary outcomes will
include relevant clinical and patient-reported parameters.

Public health relevance
Previous studies clearly established clinical benefits of pulmonary rehabilitation in patients with chronic obstructive pulmonary disease however uptake and completion rate of pulmonary rehabilitation programs by these patients is limited by multiple barriers. The goal of this project to systematically evaluate impact of Comprehensive Health Informatics Engagement Framework for Pulmonary Rehabilitation (CHIEF-PR) in a randomized controlled trial. Our main hypothesis is that CHIEF-PR will result in significantly higher rates of completion of a comprehensive pulmonary rehabilitation program.